Diversity Supplement - Diego Ruiz

PROJECT SUMMARY
This is an application for a Research Supplement to Promote Diversity in Health-Related Research to support
the graduate training of an outstanding Ph.D. student, Diego Ruiz, who meets multiple NIH criteria for an
underrepresented minority. Diego has shown extensive commitment to a career in the biomedical sciences
and has previous undergraduate research prior to starting his graduate studies at the University of New
Mexico. His long-term career goal is to conduct environmental research while devoting substantial effort to
encouraging others of underrepresented groups to consider careers in science. Doctoral training is the logical
next step to achieving his career goal. Diego and I established a mentoring team to help guide his individual
scientific development and position his for short-term success as a Ph.D. student that is competitive for NIH
F31 award. A key part of Diego’s career development plan is successful completion of a research project that
will result in two first-author publications and a submission of a F31 award. Diego’s research project is an
outgrowth of my R01 (R01ES032037; funded through 2027). The purpose of the R01 seeks to bridge the gap
in environmental health knowledge and provide insight into how MP pose a significant health risk to the general
population as well as susceptible individuals. We have found the in vivo exposure of mice to MP results in
intestinal cell lineage changes (as determined by gene expression) and can cross the intestinal barrier and
transverse to other tissues in the body; however, there appears no signs of intestinal inflammation. These two
findings suggest i) MP may influence intestinal stem cell differentiation, specifically, increasing enteroendocrine
cells and ii) the epithelial barrier is sterilizing the MP before reaching the lamina propria. Addressing these
findings is the overall goal of Diego’s project. His first aim involves performing single cell RNA sequencing and
performing bioinformatics. Aim two will be examining the lysosomal response from a molecular and
biochemical approach. Both aims require the use of intestinal organoids and co-mentor Dr. Julie In, an expert
in organoid biology, will provide training in this area. These studies will yield important understanding on how
microplastics can impact gut health. At the conclusion of his research-training period, Diego will be a well-
trained cell biologist with extensive experience in designing and conducting research and in science
communication.

Public health relevance
PROJECT NARRATIVE Plastic pollution and the breakdown of plastic materials primarily into micron-sized microplastic particles (MP) have contaminated our food and water sources, raising ecological and public health concerns. MP ingestion by humans is now an inevitable consequence of global plastic pollution and there is a critical gap in knowledge regarding how MP affects the gastrointestinal (GI) tract. The studies proposed in this NIEHS Diversity supplement grant application seek to understand how MP influence enteroendocrine cells and how the gut barrier sterilizes MP before entering into the body.